HTS for Synergistic Activators of Latent HIV-1 Infection

DESCRIPTION (provided by applicant): HIV-1 latency, which allows the virus to persist in the presence of antiretroviral therapy, is likely the major hurdle to overcome towards the development of a curative therapy for HIV-1 infection. While it is clear that the latent HIV-1 reservoir needs to be eradicated, it is unclear how this can be achieved. At the molecular biology level, current HIV-1 research focuses on the idea that molecular control of latent HIV-1 infection must be different from the control of inducible cellular genes and is characterized by the presence of a restrictive chromatin environment at the viral LTR. But how such a restrictive chromatin environment can form when the latent virus is integrated into actively expressed host-genes is unclear. How can paused RNAP II be found at the latent viral LTR, when a complex restrictive chromatin structure supposedly shields the LTR? This focus on a restrictive chromatin environment as the molecular control mechanism for latent HIV-1 infection translates into drug discovery and clinical application, where HDAC inhibitors are viewed as the holy grail of HIV-1 reactivation strategies. However, upon closer review of the literature, HDAC inhibitors, which are clinically pursued as HIV-1 reactivating agents, do not show convincing efficacy, neither in many models of latent infection, nor in ex vivo experiments or clinical studies. The possible exception is SAHA, clinically approved as the HDAC inhibitor vorinostat. SAHA exhibits some HIV-1 reactivating capacity in most experimental systems, including ours, but SAHA was initially developed as a highly potent cell-differentiating agent, using HMBA, another cell differentiating agent that reactivates latent HIV-1 as a structural template. To this end, we here report that a previous drug screen for HIV-1 reactivating drug combinations revealed that a panel of FDA-approved drugs or compounds with reported cell-differentiating capacity including dactinomycin, aclacinomycin, cytarabine and aphidicolin prime latent infection for reactivation by low-level activation. We hypothesize that cell-differentiating drugs can act to prime latent HIV-1 infection for reactivation by synergistic activators, which by themselves only exert a minimal activating effect. Thus the two objectives of the application are (i) to identify synergistic activators that trigger system-wide reactivation in combination with the priming drugs and (ii) to describe how differentiating drugs alter the cellular transcription factor profiles and signal transduction pathways to prime latent HIV-1 infection for reactivation. The goal of the application is to identiy multi-drug combinations that target latent HIV-1 infection at several levels of molecular control t trigger reactivation. This will be achieved through drug screening or by rational selection of compounds/drugs that will be enabled as we gain increasingly detailed insights into how the identified drugs alter the cellular control over the latent HIV-1 infection events.

Public health relevance
PUBLIC HEALTH RELEVANCE: HIV-1 latency is likely the major hurdle to overcome towards the development of a curative therapy for HIV-1 infection, as it allows the virus to persist in the presence of antiretroviral therapy. While it is clear that the latent HIV-1 reservoir needs to be eradicated, it is unclear how this can be achieved. Previous attempts using single drug therapy based on Histone Deacetylase (HDAC) inhibitors did not show much promise. The most promising current drug candidate to date is SAHA marketed as the HDAC inhibitor vorinostat. However, SAHA was initially developed as an extremely potent cell-differentiating agent, and its HDAC inhibitory effect was only discovered later on. It is thus interesting that we identified several FDA-approved drugs and compounds that also have cell-differentiating capacity (e.g. aclacinomycin, dactinomycin, cytarabine, aphidicolin) as agents that potently prime latent infection for reactivation by low-level stimuli. In this application we will detail how these drugs change the transcription factor profile of the host-cells to lower the "HIV-1 reactivation threshol" and will perform a drug screening campaign to identify synergistic activators that will act in combination with the priming drugs to trigger specific and efficient HIV-1 reactivation. We view this research as a first step to move away from the magic bullet approach, where one drug is expected to achieve complete system wide reactivation, closer to the development of likely more promising drug combination approaches using the complex chemotherapeutic schedules for the successful treatment of childhood leukemia as blueprints. __SpecificAimsTextDelimiter__ AIMS In many models of latent HIV-1 infection including some primary T cell-based models, specific HDAC inhibitors fail to trigger efficient HIV-1 reactivation (9, 14, 45, 54). Recent studies from the Fauci/Chun laboratory suggest at best a limited impact of HDAC inhibitors, including valproic acid and SAHA on latent HIV- 1 infection in patient derived T cell populations (ex vivo) (6). Boosting HAART with HDAC inhibitors has not produced any relevant reduction of the latent HIV-1 reservoir in patients (39-41). Pharmacological perturbation data thus do not support the idea that a restrictive histone code/chromatin environment is key to controlling latent HIV-1 infection. Nevertheless, HDAC inhibitors are pursued as the sole solution to HIV-1 eradication, to the exclusion of other ideas. Currently, SAHA/vorinostat is tested in patients and the Margolis group reported that SAHA would induce viral RNA production in patients on successful HAART and in ex vivo material from these patients (4). However, while being promoted as a HDAC inhibitor, SAHA was initially developed as a potent cell-differentiating agent (34, 35), using HMBA, another differentiating agent reported to trigger HIV-1 reactivation (12, 46) as a structural template. Its HDAC inhibitory effect was only discovered later on (34), rendering SAHA into a bi-modal drug. In a drug screen leading to this application we identified several cell- differentiating agents, some of which are FDA-approved drugs that prime latent HIV-1 infection for reactivation. In combination with certain low-level activating stimuli, these drugs/agents exhibited potent synergistic HIV-1 reactivating effects. In a second line of research, we identified (i) kinase inhibitors that would prevent reactivation without limiting NF-κB activation and we identified (ii) an AP-1 site in the CD28 responsive element of the LTR that if altered based on naturally occurring differences between HIV-1 subtypes would either increase or abolish latency establishment. Together with our finding that HIV-1 infection itself ((iii) induced epigenetic changes of the host cell that alter the cellular NF-κB response, we hypothesize that latent infection, as the expression of cytokine genes with similar CD28RE controlled promoters is primarily governed by transcription factor restriction beyond NF-κB or TFIIH restriction. Cell differentiating drugs are known to temporarily or permanently alter the transcription factor profile of cells, and we propose that the identified differentiating drugs at several levels reverse the restrictive molecular mechanisms that control latent infection. In this application, we will seek to identify clinically relevant low-level activating stimuli that synergistically act in conjunction with the identified priming drugs to trigger HIV-1 reactivation and we will detail how the identified drugs/compounds exactly act on the host cells and on latent HIV-1 infection. AIM 1: Identification of priming drugs and synergistic activator compounds to trigger HIV-1 reactivation. This drug discovery campaign is the center of the application. In this aim, we will transfer a drug screening assay based on HTS flow cytometry to a robotic platform and initiate a drug screening effort to identify activating stimuli that act synergistically with the already identified priming drugs to trigger HIV-1 reactivation. As our data suggest that latent HIV-1 infection is controlled by transcription factor restriction, we will base the screen on a 50,000 compound library with a strong bias for compounds targeting kinase activity. In addition, we will screen libraries (SPECTRUM, LOPAC, in-house collection) that consist of compounds/drugs with known activity. We will further systematically test reported cell differentiating drug/compounds for their ability to affect latent HIV-1 infection. AIM 2: Dissecting the molecular basis of priming latent HIV for reactivation. Based on a body of literature and our findings, we operate under the assumption that latent HIV-1 is controlled by transcription factor restriction, similar to cellular genes with related promoter structures, such as IL-2, IL-8, TNF-α or CD25, all of which are also not expressed in memory T cells, which are the primary host cell type for latent HIV-1. Transcription factor restriction may further be promoted by epigenetic changes we observed in the host cells, induced by the actual infection event, some of which target the NF-κB signaling pathway. In this aim, we will investigate which signal transduction pathways and transcription factors are targeted by the identified drugs, and how they act at the molecular level to prime latent infection for reactivation. Identification of the specific molecular restrictions that are removed or reversed by the priming drugs will likely reveal molecular drug targets and may provide us with the ability to rationally design HIV-1 reactivation combination therapies using a drug repositioning approach.